The role of vascular lipids in Alzheimer's disease pathophysiology

Project Summary
Cerebral blood vessels are critical to deliver oxygen and nutrients to the brain, and to remove carbon
dioxide and other waste products. Although just 2% of the body’s weight, 20% of the circulation is directed to the
brain, highlighting the importance of the cerebral vasculature to the health and function of the brain. Blood
vessels that vascularize the central nervous system (CNS) harbor distinct physical, transport, metabolic, and
signaling properties, termed the blood-brain barrier (BBB). Manifested within the endothelial cells (ECs) that line
the lumen of the CNS vasculature, these BBB properties stringently regulate the movement of molecules, ions,
and cells between the blood and the brain, allowing for proper neuronal function and safeguarding the neural
tissue against injury and disease. As such, many neurological diseases are associated with BBB disruption,
including multiple sclerosis (MS), epilepsy, and stroke.
Recently it has been suggested that BBB dysfunction may contribute to the pathogenesis of Alzheimer’s
disease (AD); however, the extent, nature, and contributions of this dysfunction to AD pathophysiology remains
enigmatic. To identify nuanced changes to the brain vasculature in AD, a vascular-specific proteomic approach
was employed. This approach revealed down-regulation of many enzymes involved in fatty acid and lipid
biosynthesis, namely ELOVL fatty acid elongase 7 (ELOVL7), in the cortical vasculature of AD patients compared
to controls. From here, this proposal will test the hypothesis that aberrant vascular lipid metabolism is a critical
component of AD pathophysiology. Many classes of lipids have been implicated in regulating the trafficking and
proteolytic activity of disease-relevant enzymes in AD. As lipid signaling is critical to brain homeostasis, vascular
integrity, and AD etiology, identification of the lipidomic changes occurring at the BBB during AD could give
important insight about the pathogenesis of AD and potentially identify novel therapeutic targets that can be used
to normalize the BBB in AD patients.
While ELOVL7 has never been studied in brain ECs or in the context of AD, previous studies have
revealed that ELOVL7 is uniquely enriched in brain ECs in both mice and humans. Further, brain EC-specific
transcriptomic approaches have shown dynamic loss of ELOVL7 expression in neuroinflammatory mouse
models with known BBB disruption. Data such as these, taken together with the finding that ELOVL7 is
decreased in the brain vasculature of patients with AD, steers this proposal towards the hypothesis that ELOVL7
may be critical to BBB function and that its downregulation may contribute to AD etiology. This hypothesis will
be tested in vivo by conditional deletion of ELOVL7 within brain ECs of mice. Understanding the role of ELOVL7
at the BBB may elucidate crucial mechanisms of AD pathophysiology, and its downstream fatty acid metabolites
may prove to be viable therapeutics to normalize the brain vasculature in AD.

Public health relevance
Project Narrative The proposed project will test the novel hypothesis that aberrant vascular lipid metabolism is a component of Alzheimer’s disease (AD). To do so, I will identify the molecular changes to the brain vasculature in patients with AD and will then model these changes in mice to clarify their relevance to vascular function and AD pathophysiology. This study may provide meaningful insights into the role of the cerebral vasculature in dementias such as AD, and may reveal novel therapeutic avenues for patients with AD.